Animal Imaging Shared Resource

ABSTRACT
Overview: The Animal Imaging Shared Resource (AISR) provides access to state-of-the-art animal scanners
and expertise to study tumor progression, metastases, microenvironment and response to therapies using non-
invasive imaging in animal models of cancer. The AISR, created in 2006, is the only comprehensive high-end
Animal Imaging facility in Colorado. The AISR supports cancer research with high-end imaging services,
validation of novel contrast agents, collaboration and training in animal imaging, study design, quantitative image
analysis and translation of imaging technologies to human clinical trials. Equipment: Since the last renewal, the
AISR worked diligently to leverage extramural and institutional funding to upgrade and maintain cutting edge
imaging equipment, resulting in $4.3M in capital equipment investments since 2016. The AISR has added three
state-of-the-art preclinical scanners - a Bruker 9.4 Tesla MRI, an IVIS Spectrum, and a Quantum GX2 CT to the
existing Siemens Inveon PET/CT, Mediso SPECT/CT, IVIS200 and Bruker 4.7 Tesla MRI. Services and
Expertise: The AISR, located within the UCAMC Animal Facilities, offers easy access to advanced imaging
equipment and full-service support for imaging studies including study design, IACUC approved protocols,
animal handling, image acquisition, multimodal image analysis, and preparation of grant proposals, study reports
and publications. In addition to ultra-high resolution (20-50 microns) anatomical imaging, the AISR has
established advanced imaging protocols for tumor physiology and microenvironment such as diffusion weighted/
tensor imaging (DWI/ DTI), dynamic contract-enhanced MRI (DCE-MRI), vessel-size imaging (VSI), iron oxide
macrophage MRI, metabolic PET and peptide SPECT/CT protocols. Dr. Natalie Serkova, AISR Director since
2006, has developed a robust imaging research infrastructure, based on her MR physics/ animal imaging
expertise. Consultation and Education: The AISR offers advanced imaging and image analysis workshops
regionally twice per year to enhance researchers' in-vivo study designs. Since 2016, over 300 participants across
the State have enrolled in the AISR workshops. Management: The AISR is an institutional shared resource
managed by the UCCC. Operating Budget: CCSG funding represents 42% of the current operating budget.
Remaining support is from user fees (54%) and institutional support (4%). NIH shared instrumentation grants,
matching institutional support and CCSG subsidies are critical to AISR's mission to serve UCCC members at
the uppermost level possible while minimizing costs in a relatively expensive technology-centric field. Use of
Services: Since 2016, 97 investigators have used the AISR, 42% (n=41) of whom were UCCC members who
accounted for 66% of the total use. Future Directions: AISR is working to acquire two new imaging systems, a
hands-free ultrasound and an upgraded PET/CT. The added scanners and continuing educational efforts will
increase animal imaging applications in studies of tumor detection, microenvironment, and treatment response
enhancing cancer research and ultimately the quality of life and survival for cancer patients.